Targeting GRK2 (BARK1) in Heart Failure

Targeting GRK2 (βARK1) in Heart Failure ABSTRACT Heart Failure (HF) continues to grow in the country and is a burden to the health care enterprise. HF often occurs after myocardial injury or stress such as ischemia or pressure-overload with cardiac hypertrophy occurring first, followed by ventricular remodeling and a loss of contractile function and β-adrenergic receptor (βAR) -mediated inotropic reserve. The G protein-coupled receptor (GPCR) kinase 2 (GRK2 or βARK1) plays a key role in the dysregulation of βAR signaling in the hypertrophied and failing heart. Studies in transgenic mice using a peptide inhibitor of GRK2 (known as the βARKct) and also cardiac-specific GRK2 knockout (KO) mice suggest that GRK2 is a target to improve contractile function and βAR-mediated inotropic reserve in HF. Of interest to this competitive renewal application, new data with βARKct expression in hearts and emerging data from GRK2 KO mice suggest that there are consequences of GRK2 inhibition or gene silencing that go beyond βAR-mediated contractile function. For example, cardiac GRK2 KO mice have significantly limited myocyte hypertrophy in response to left ventricular (LV) pressure-overload, a phenotype also seen in βARKct mice with higher transgene expression. This occurs without the mice going into HF suggesting that GRK2 and its activity facilitate maladaptive cardiac hypertrophy. These data support the increasing evidence that a large and dynamic GRK2 interactome exists in cells and extends GRK2 activity and regulation to proteins outside of GPCRs. Molecules shown to interact with GRK2 such as tubulin and Akt suggest that this GRK may play roles in adaptive myocyte shape and size as well as cell survival. In addition, GRK2 can be found in/on mitochondria in cardiac myocytes through novel protein-protein interaction via the amino-terminus of GRK2. Moreover, interesting data from non-myocytes have shown that GRK2 negatively affects insulin signaling and glucose metabolism. Specifically, GRK2 has been shown to inhibit the translocation of the glucose transporter, GLUT4, to cell membranes with consequential insulin resistance. Thus, regulation of glucose uptake, which is critical as an energy substrate in the ischemic and failing heart, could be an important novel target of GRK2 action. In this competitive renewal application we are interested in elucidating critical βAR-independent actions of GRK2 in the heart and knowing whether βARKct-mediated GRK2 inhibition or loss of GRK2 expression promotes novel beneficial pathways in the stressed and compromised cardiomyocyte. The Central Hypothesis of this proposal is that GRK2 plays a critical role in pathological cardiac hypertrophy, ventricular remodeling and HF via mechanisms beyond GPCR desensitization, and this is determined by novel interactions and localization within the cardiomyocyte. Testing of this hypothesis will also show that lowering GRK2 expression is a novel strategy to improve the function of the failing heart. Our associated Specific Aims are: [1] To determine whether novel, non-GPCR desensitizing functions of GRK2 play a facilitative role in the pathogenesis of maladaptive cardiac hypertrophy; [2] To investigate the in vivo role of GRK2 in dysfunctional myocardial glucose uptake of ischemic myocardium and to determine the cellular mechanisms in myocytes of how GRK2 regulates glucose metabolism and insulin signaling; [3] To determine whether viral- mediated gene transfer of an artificial micro-RNA that targets and silences GRK2 expression offers a novel therapeutic strategy for pathological hypertrophy and ischemic HF.

Public health relevance
Narrative (Relevance): Since expression levels and activity of GRK2 are elevated in failing myocardium including in human heart failure (HF), uncovering novel mechanistic aspects of this GRK using our unique animal models and molecular reagents will lead to a broader understanding of the pathogenesis of hypertrophic and ischemic cardiac dysfunction. Moreover, our translational studies described will prove that GRK2 is an innovative therapeutic target for HF.